Single-molecule dissection of a tumor- and virus-suppressing Smc complex involved in genome maintenance

Project Summary/Abstract
The structural maintenance of chromosomes (Smc) 5/6 complex plays a critical role in tumor suppression and
the repression of tumor-causing viruses, such as the hepatitis B virus. Smc5/6 exerts these clinical functions by
promoting faithful genome replication, coordinating DNA repair, and silencing extra-chromosomal DNA.
However, there is little understanding of how Smc5/6 operates as a molecular machine, hindering our ability to
intervene in Smc5/6’s health-related functions. Our central hypothesis is that Smc5/6 operates as a dynamic
molecular machine that compacts DNA, intrinsically binds to DNA fork junctions, and co-localizes with replication
factors. The long-term goal of this research is to understand how defects in Smc5/6 promote genome instability
and malignant transformation.
This project’s immediate objective is to elucidate the biophysical properties of the Smc5/6 complex by utilizing
correlative single-molecule fluorescence and force microscopy, which combines optical tweezers, automated
microfluidics, and multi-color confocal microscopy. In Specific Aim 1, Smc5/6’s DNA compaction abilities will be
assayed on individual DNA tethers. The effect of the subunits of Smc5/6 and ATP will be systematically tested.
The outcome of this work will define the role of each of these components on Smc5/6’s DNA compaction
behavior. In Specific Aim 2, the binding behavior and dynamic movement of fluorescently-labeled Smc5/6 will
be monitored on double-stranded DNA, single-stranded DNA, and fork junctions in real time. In Specific Aim 3,
Smc5/6’s interactions with replication factors will be defined by a first-of-its-kind in vitro reconstitution of the
eukaryotic replisome.
Overall, this project will: (1) consolidate our understanding of Smc5/6 at the molecular level; (2) yield important
insights into how eukaryotes maintain genome integrity and suppress tumors; and (3) potentiate new strategies
to modulate Smc5/6’s physiological functions as a tumor suppressor and host restriction factor. Dr. Xiaolan Zhao,
an expert on Smc5/6 biology who has a proven track-record for training successful scientists, and Dr. Shixin Liu,
an expert on single-molecule technology who practices active mentorship, are co-sponsoring this proposal. The
research efforts will take place at the Rockefeller University within the deeply supportive Tri-Institutional MD-
PhD Program. This proposal and fellowship is an important career milestone for dual-degree students seeking
to become independent investigators.

Public health relevance
Project Narrative The Smc5/6 complex is a conserved protein complex whose roles in genome replication, DNA repair, and suppression of extra-chromosomal DNA underlie its clinical functions of tumor suppression and repression of tumor-causing viruses. To address the mechanistic knowledge gap of how Smc5/6 operates as a molecular machine, this proposal aims to: (1) characterize Smc5/6’s ability to manipulate and compact DNA; (2) elucidate the binding preferences of Smc5/6 on DNA substrates of different topologies; and (3) define Smc5/6’s interactions with DNA replication factors. Completion of this project will contribute fundamental knowledge to how cellular systems maintain genome integrity and advance the prospect of establishing Smc5/6 as a therapeutic target to treat cancer and viral infections.